Georgia Pregnancy Risk Assessment Monitoring System

Project Summary The Georgia Pregnancy Risk Assessment Monitoring System (PRAMS) is a statewide, ongoing, population?based survey that collects information on women who have recently had a live birth in Georgia. Georgia PRAMS initiated sampling with January 1993 births. PRAMS survey data complements Vital Statistics by asking mothers about their attitudes, behaviors, and experiences before, during, and shortly after pregnancy. Survey topics include preconception health, pregnancy intention, prenatal care, health insurance, substance use, breastfeeding, safe sleep behaviors and environment, intimate partner violence, maternal stressors, contraception use and methods, etc. Each month a random sample of approximately 200 women is drawn from the birth file and stratified by maternal resident county. The six oversampled counties are Bibb, Chatham, Fulton, Lowndes, Muscogee, and Richmond. Women are surveyed two to six months post?delivery first by mail and then by phone if they have not completed the survey. Each mother's survey is linked to her baby's birth certificate. The goal of Georgia PRAMS is improve the health of mothers and babies in Georgia by reducing the risk of adverse birth outcome such as low birthweight, preterm birth, and infant or maternal morbidity and mortality. Georgia PRAMS provides essential data allowing for the identification of high risk groups, selection of maternal and child health priorities, establishment of prevention programs, and policy changes that can improve the health of mothers and babies in Georgia.

Public health relevance
Project Narrative The Georgia Pregnancy Risk Assessment Monitoring System (PRAMS) will continue to collect data on women's attitudes, experiences, and behaviors before, during, and shortly after delivering a live birth. Mothers will be contacted by mail and phone and web when it becomes available. The information gained from this surveillance system will be used to identify maternal and child health risk factors of adverse birth outcomes, target population at greatest risk, develop interventions, and inform policy that will improve the health of mothers and babies in Georgia.